Genetic and Metabolic Determinants of Bacterial Interspecies Interactions

Interspecies interactions are the foundation of bacterial community formation and function. Through their
interactions, bacteria exert powerful influences on human health as commensal microflora, pathogens,
biofilms, and antibiotic producers. A prevalent form of interaction among bacterial species relies on the
exchange of specialized metabolites. Commonly represented by antibiotics, these bioactive metabolites
function in myriad ways to promote the fitness of the producing species. Specialized metabolites may be toxic
or growth inhibitory, or alternatively, they may function as signals and cues to relay information between
species in a microbial community. Despite their importance for interactions between species, there is little
understanding of the mechanisms that bacteria use to sense and respond to foreign specialized metabolites.
This project focuses on an early-warning system for competitors, wherein bacteria detect specialized
metabolites from other species and respond by activating a surface-mobile population. This example of an
adaptive physiological response to a competitor provides the bacteria an opportunity to either escape or to
counterattack. This project has two specific aims. The first aim is to define the mechanisms that activate and
control bacterial motility when bacteria are exposed to specialized metabolites from a competitor. In particular,
this aim will focus on major changes in metabolism and the controlling genetic functions that support a
transition to a mobilized population. The second aim is to identify new motility-inducing metabolites produced
by competing bacteria. Previously identified inducers are protein synthesis inhibitors that stimulate motility at
subinhibitory concentrations. New inducers of unknown structure will be identified from different strains of
bacteria. These inducers will expand knowledge of chemical forms that induce surface mobilization and will
function as chemical probes to understand the pathways to activating the mobile response. Because inducers
include protein synthesis inhibitors, new candidate antibiotics may be identified among the target specialized
metabolites. Overall, these studies will advance understanding of specialized metabolism in dynamic
interactions between bacterial species and how a mobile response promotes competitive fitness.

Public health relevance
This project is relevant to human health through its focus on bacterial interspecies interactions, which are fundamental to the formation and function of dynamic communities such as the human microbiome. The mechanisms evolved by bacteria to sense and respond to different species of bacteria are poorly understood. The project is relevant to the mission of NIH for the fundamental discoveries of bacterial adaptive physiological responses to competitor species and to the discovery of specialized metabolites that induce these responses.